Long-Term Alcohol Use Effects of a Training Intervention for ADHD

Project Summary/Abstract
The long-term objective of the proposed study is to identify a putative intervention mechanism of
change for altering the developmental trajectory of alcohol use problems among an at-risk population. To attain
this goal, the applicant will receive advanced training in risk factors of alcohol use, multi-method data design
and collection, and quantitative skills via coursework, lab rotations, workshops, and consultation. This is an
important area of research as adolescents with ADHD are at-risk for experiencing alcohol-related problems 5,6
and developing alcohol use disorders as emerging adults 3, 4. The applicant’s team previously implemented a
training intervention for adolescents with ADHD, and preliminary investigations revealed this intervention was
the first intervention for youth with ADHD to be associated with positive treatment-related gains in alcohol use
problems 7. The magnitude of these differences grew over time, consistent with findings of other outcomes from
this intervention 14. Thus, this intervention may alter the developmental trajectory of alcohol use problems for
adolescents with ADHD. A leading developmental biopsychosocial model of the link between ADHD and
alcohol use problems 10 highlights the critical role of emotion dysregulation (ED) in catalyzing risk for alcohol
use problems among individuals with ADHD. Thus, the goals of the current study are to examine the durability
of improvements in alcohol-related problems as the youth transition into emerging adulthood, a time when
alcohol use peaks 2, and to examine ED as a putative mechanism of change in the pathway to problematic
alcohol use. Efforts will be made to retain the original sample of adolescents with ADHD (n = 171) who
previously participated in a randomized controlled trial of a training intervention while in high school.
Participants provided self-report of alcohol use behaviors and ED at 3 points over the previous 3 to 5 years. In
the proposed study, participants will report their current patterns of alcohol use and associated problems. To
enhance our understanding of the complex construct of ED, ED will be measured via multiple units of analysis
(i.e., self-report, physiological, behavior). Structural equation modeling will be employed to address the
following aims: (1) examine intervention effects on alcohol use problems; (2) examine intervention effects on
ED; and (3) examine the association between ED and alcohol use problems, and, in an exploratory aim,
examine whether intervention has an effect on alcohol use problems via ED. Sex will be explored as a
moderator across these aims given evidence of potential sex-specific pathways to use among individuals with
ADHD 55-58. The proposed study has the potential to identify an intervention mechanism of change to be
targeted in future interventions that may reduce the detrimental outcomes experienced by youth at-risk of
alcohol use problems. Further, the training afforded to the applicant through this fellowship will enhance her
ability to conduct basic and mechanistic research necessary for a career as an independent researcher
capable of conducting intervention development and evaluation research for at-risk youth.

Public health relevance
Project Narrative Alcohol use contributes to the leading causes of death among emerging adults 2, and emerging adults with ADHD are at greater risk of experiencing alcohol-related problems than their peers without ADHD 3,4. A recent RCT with an intervention developed by our research team revealed improvements in rates of alcohol- related problems for youth with ADHD, and the proposed project will examine the durability of these effects as youth transition into emerging adulthood. Further, I will examine a putative intervention mechanism of change (i.e., emotion dysregulation) and consider sex-differentiated pathways to problematic use in order to inform development of streamlined interventions capable of producing potent, long-term effects for youth at-risk of alcohol use problems.